Development and Piloting of a Stigma Assessment Tool for Global Pediatric Cancer

Project Summary/Abstract:
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-CA-
23-036”, as a supplement to the St. Jude Comprehensive Cancer Center (SJCCC) P30. The overarching goal
of this study is to develop a content-appropriate, clinically meaningful, psychometrically validated tool to
measure stigma in pediatric oncology. A core objective of the SJCCC is to increase access to cancer care,
improve survival rates, and optimize quality of life for children across the globe. As part of this goal, the SJCCC
seeks to understand the role of social and cultural factors, such as stigma related to cancer diagnosis and
treatment, that may reduce cancer care acceptance and treatment adherence globally. Stigma is defined by
the World Health Organization as the “negative association between a person or group of people who share
certain characteristics and a specific disease” that may lead to stereotyping, discrimination, and social isolation
of those affected. Stigma has been demonstrated to affect healthcare acceptance as well as treatment
outcomes for patients with a myriad of health conditions, including adult cancers. However, stigma has been
understudied among global pediatric cancer populations. Over 90% of children diagnosed with cancer live in
low- and middle-income countries (LMICs). In these settings, stigma has been noted to affect the quality of
cancer care delivery and contribute to treatment abandonment, a leading cause of death for children with
cancer in LMICs. In survivors of childhood cancer, stigma contributes to psychological distress, impacts school
and social functioning, and affects adherence to follow-up care. No pediatric specific stigma tool currently
exists, and tools to measure stigma within other health conditions are primarily focused on adults and were
contextually developed in high-income countries, making them insufficient for use in global pediatric cancer
populations. The aims of this proposed study are to 1) develop a clinical tool that can be used to identify
and measure stigma as experienced by pediatric oncology patients and survivors in culturally diverse
global settings, and 2) pilot this new stigma tool in geographically and culturally diverse cancer referral
settings in the United States, Guatemala, and Jordan. Our process for tool development will include a
systematic review of the literature, concept mapping building off preliminary qualitative work conducted by our
study team, a Modified Delphi (15 experts), and cognitive debriefing (36 participants). Our pilot study will
include patient and survivor participants aged 8-17.9 (n=250-300) from four cancer centers: St. Jude Children’s
Research Hospital (Memphis), St Louis Children’s Hospital (St. Louis), King Hussain Cancer Center (Jordan)
and Unidad Nacional de Oncologia Pediatrica (Guatemala). This study will produce a reliable, valid, and usable
clinical assessment tool for stigma in diverse global pediatric oncology settings across the care continuum.
1

Public health relevance
Project Narrative: This measurement development study utilizes pragmatic design principles and mixed-methods, including psychometric and usability testing. It draws on an experienced team of experts in global pediatric oncology and measurement development to develop and pilot a clinical tool that can be used to identify and measure stigma in diverse global pediatric oncology populations. Development and validation of a stigma assessment tool is necessary to enable interventions that will be used to decrease the impact of stigma on children with cancer worldwide. 2